RESPIRATORY PATTERNS, APNEAS, HYPOPNEAS, AND OXYGEN SATURATION DURING SLEEP

The purpose of this study will be to find and study those patients with neuromuscular disorders in the adult and pediatric population that may have breathing problems with breathing during sleep.